Effectiveness and Implementation of mPATH-CRC: a Mobile Health System for Colorectal Cancer Screening

Colorectal cancer (CRC) is the second-leading cause of cancer death in the United States. Screening for CRC
reduces mortality and is widely recommended for all adults starting at age 50, yet over 35% of Americans
remain unscreened. To address the multiple barriers to CRC screening (patient, clinician, and system), our
team developed mPATH-CRC (mobile PAtient Technology for Health-Colorectal Cancer), a patient-friendly
iPad program used by individuals immediately before a routine primary care visit. mPATH-CRC is a CRC
screening decision aid that helps patients make a screening decision, allows patients to “self-order” a CRC
screening test, and minimizes provider and system barriers. After the visit, mPATH-CRC automatically sends
patients who choose to be screened supportive text messages at key times to help them complete their chosen
test. In our recently completed randomized controlled trial of 450 diverse patients (R01CA178941), mPATH-
CRC doubled the proportion of patients who completed CRC screening. To fully realize mPATH-CRC's
potential to decrease CRC mortality, the program now must be implemented in primary care practices in a way
that encourages routine and sustained use. However, while hundreds of mobile health (mHealth) tools have
been developed in recent years, the optimal strategies for implementing and maintaining mHealth interventions
in clinical practice are unknown. We have developed a “high touch” mHealth implementation strategy based
on our prior research and guided by the Technology Acceptance Model and the Dynamic Sustainability
Framework. Our strategy leverages evidence-based elements including clinic champions, facilitation, regular
data feedback, follow-up training, and adaptation. Our team now proposes to compare the results of the “high
touch” strategy to a “low touch” strategy using a Type III hybrid study design and incorporating mixed methods
to evaluate implementation, maintenance, and effectiveness of mPATH-CRC in a diverse sample of
community-based practices. The Specific Aims of the proposal are to: 1) in a cluster-randomized controlled
trial of 28 primary care clinics, compare the implementation outcomes of a “high touch” evidence-based
mHealth implementation strategy with a “low touch” implementation strategy; 2) in a nested pre-post study,
estimate the effect of mPATH-CRC on completion of CRC screening within 16 weeks of visit; and 3) determine
the factors that facilitate or impede the maintenance of mHealth interventions like mPATH-CRC by surveying
and interviewing clinic staff and providers as part of a mixed-methods analysis. This project could decrease
CRC morbidity and mortality by translating our evidence-based CRC-screening intervention into community
practice, directly addressing the goals of Healthy People 2020 and the National Cancer Moonshot. Importantly,
completion of these aims will yield essential information for successful implementation of other technology-
mediated interventions in primary care settings, addressing a current gap in knowledge.

Public health relevance
mPATH-CRC is an innovative iPad app that patients use before a primary care medical visit to help them receive colorectal cancer screening, a widely recommended test that decreases mortality. However, while hundreds of health apps have been developed in recent years, the best strategies for incorporating apps in routine primary care remain unknown. This project will determine the optimal way to implement mPATH-CRC and other technology-based programs in community-based primary care practices, increasing the use of life- saving screening tests and improving the delivery of medical care.